University of Kansas' Precision Biologic Interventions for Severe Exacerbation Prone Asthma (PrecISE) Clinical Center

Abstract – Washington University's PrecISE Clinical Center
The overall impact of severe asthma on individuals affected by this disease as well as society is
substantial. Treatment for severe asthma is now focusing on tailoring treatment to particular phenotypes
driven by the endotypes yet the evidence for this approach is lacking. Key phenotypes which have
supporting evidence for appropriate biomarkers and therapy based on their endotype include eosinophilic-,
T2- and mucin-driven disease states. This proposal contains a precision-medicine, biomarker-driven, highly
novel adaptive controlled trial to establish a new treatment paradigm for severe asthma as proposed by the
NHLBI's Precision Interventions for Severe and/or Exacerbation Prone Asthma (PrecISE) Network RFA. In
the current proposal, our overall hypothesis is that a specific phenotype (eosinophilic, T2 or mucin) will
respond better to a biologic therapy targeted specifically to that phenotype than an empirical approach.
Specifically, we hypothesize that patients with the following phenotypes will differ in treatment responses: i)
eosinophilic - treatment with anti-IL5 or anti-IL4Rα monoclonal antibody (mAb) is superior to anti-IgE, ii) T2 -
treatment with anti-IL4Rα or –IL5 is superior to anti-IgE and iii) mucus - treatment with either anti-IL4Rα or -
IL5 is superior to anti-IgE. In this adaptive trial design, we will use two short-term response indicators,
improvement in FEV1 of 100 ml or greater from baseline and/or improvement in asthma control (ACQ) score
of 0.5 or greater, to determine if the patient is responding or not. The primary endpoint will be the asthma
exacerbation rate. Accordingly, our specific aims are to study adolescent and adult patients with severe
persistent exacerbation-prone asthma to:
Aim I. Evaluate which biologic therapy, anti-IL4Rα, anti-IL5 or anti-IgE mAb, is most effective among
patients with eosinophilic asthma (blood eosinophil ≥300 cells/µL) who demonstrate a short term-
response and which demonstrates an acceptable safety profile.
Aim II. Evaluate which biologic therapy, anti-IL4Rα, anti-IL5 or anti-IgE mAb, is most effective among
patients with T2 asthma (high T2 sputum signature) who demonstrate a short term-response and which
demonstrates an acceptable safety profile.
Aim III. Evaluate which biologic therapy, anti-IL4Rα, anti-IL5 or anti-IgE mAb, is most effective among
patients with mucus-driven asthma (high mucus score on qCT chest) who demonstrate a short term-
response and which demonstrates an acceptable safety profile.
Aim IV. a. Determine whether airway remodeling (change in qCT wall area) is modified by biologic therapy.
Aim IV. b. Evaluate the ability of a positive short-term response within each biologic therapy to predict
exacerbations and airway remodeling.

Public health relevance
Relevance Evidence for the treatment of severe asthma focusing on tailored treatment to their particular disease (phenotype) is lacking. This proposal contains a novel adaptive trial design to do the first direct comparison study of three biologic therapies (anti-IL4Rα, anti-IL5, and anti-IgE) in patients with severe exacerbation prone asthma that will change our current management of these patients.